Longitudinal Follow-Up of 9/11 Directly Exposed Children in their Age of Transition: Independence, Occupation and Morbidity

When the World Trade Center was attacked on September 11, 2001, approximately 25,000 children were living
or attending school in lower Manhattan, tens of thousands of other children were in the path of the plume. As we
approach the 20th anniversary, it becomes clear that while we have thoroughly studied those exposed on 9/11
as adults, we did not adequately study those children, whose development was interrupted by 9/11. Those
children are now in their early to mid-adulthood and many will carry the effects of 9/11 for a lifetime. There is,
thus, a clear imperative to thoroughly understand the enduring impact of that exposure on all aspects of their
lives now and going forward. Fortunately, our team, The Global Psychiatric Epidemiology Group at Columbia
University, was funded by NIOSH to recruit a representative sample (N=xx) of 9/11 directly exposed youth who
were ages 0-17 on 9/11, as well as an unexposed control group. We have followed them through two waves of
in-depth physical and psychological assessments. This cohort now constitutes the best available opportunity to
understand the intricacies of the impact of 9/11 on adults who were exposed as children. In this study we propose
to study the impact of childhood trauma on the central challenges, roles and relationships of entering and
occupying adulthood, in addition to continuing the study’s collection of vital longitudinal information.
We have this important opportunity now to compare those exposed with controls, which will enable us to examine
how trauma affects intimacy and family formation, education and career consolidation, moral development and
civic engagement, and the challenge of parenting, with a traumatic history. It represents a unique opportunity to
add to our understanding about the nature of their unfolding adulthood, psychologically and physically. We will
conduct another wave of in-depth assessments of psychological and physical health including pulmonary health
and related parameters, and we will collect and biobank blood for a second time to allow for the future
examination of inflammatory and epigenetic biologicals. As the long-term consequences of 9/11 direct exposure
now inevitably includes these individuals’ experience with COVID-19, so this study will also evaluate the effects
of an additional mass trauma on these emerging adults. In sum, this study will encourage new ways of thinking
about trauma, development from childhood to mid-life, health promotion, and even parenting support of those
traumatized as children.

Public health relevance
As we approach the 20th anniversary of 9/11, the focus of this study is to thoroughly examine the long-term consequences of being exposed to 9/11 as a child, including mental and physical health, adult development, role functioning, relationships, independence and parenting Using our thoroughly characterized ongoing longitudinal, representative cohort of 9/11 directly exposed children, we will now conduct a third wave of physical and psychological assessments and add a thorough examination of adult developmental achievements and challenges. This will result in the largest, longest and most thoroughly studied cohort of 9/11 exposed children, and will give us the knowledge to mitigate their suffering and improve their lives, as well as the lives of children exposed to mass trauma in the future.